Administrative Core

ADMINISTRATIVE CORE SUMMARY The mission of the Administrative Core is to support and promote the scientific and outreach goals of the Cancer Cell Map Initiative (CCMI). Amongst its responsibilities, the Core will perform the following: provide leadership that ensures strong oversight and representation of all stakeholders in decisions? facilitate integration of research projects? connect the CCMI to the broader NCI Cancer Systems Biology Consortium? and manage the solicitation, review and funding of pilot projects. Day­to­day activities will be coordinated by a cross­campus team consisting of the CCMI Directors (Dr. Nevan Krogan, the contact PI, and Dr. Trey Ideker), the Assistant Director (Dr. Jason Kreisberg) and the Center Administrator (Donna Even­Kesef). The entire leadership team, equally split between UCSF and UCSD, has extensive experience leading and managing large research centers. We will also form a Steering Committee consisting of the Directors and Co­Investigators, which will evaluate the progress and needs of each component, review and possibly modify priorities, and identify areas deserving extra focus. An External Advisory Committee (EAC) will be formed to review the Center’s progress and future plans. To facilitate communication amongst Center members and with the other members of the Cancer Systems Biology Consortium including the Coordinating Center, the Administrative Core will organize and manage a number of regularly scheduled meetings, some specifically for members of the Steering Committee and others for the entire CCMI. These various meetings will provide ample opportunities to discuss overall research directions and specific experimental concerns. The Core is already organizing a workshop for late September of 2016, which will feature talks by all 10 CCMI faculty members along with talks from 12 other faculty members from UCSF, UCSD, Stanford, Harvard and others.In collaboration with the Outreach Core and the Bioinformatics Core (Core 2), the Administrative Core will assist in the maintenance of the CCMI website (www.ccmi.org) and shared file servers. To provide formal site review and involvement with NCI, the Core will organize an annual EAC Meeting, in which the PIs and key personnel will meet with the EAC and NCI program staff to review the Center’s activities. The EAC Meeting will be held in conjunction with an annual Cancer Network Biology Symposium. Finally, the Core will design, solicit and manage the award process for Intra­center Pilot Projects. This program will provide researchers from outside the CCMI the opportunity to enhance the Center’s overall research objectives through the short­term exploration of highly innovative, high­risk concepts. Funding for pilot projects will be supplemented with an additional contribution of $100,000, half from the Chancellor of UCSF and half from the Dean of Medicine from UCSD. Overall, the Administrative Core will ensure that projects are productive, synergistic and have sufficient support? that resource­sharing obligations are met? and that outreach activities are of maximum impact.